CHRONIC TRANSFUSION AND THERAPY FOR REFRACTORY ANEMIAS (SICKLE CELL)

This is a long-term study to determine the efficacy of desferrioxamine in the treatment and prophylaxis of iron overload due to chronic transfusion therapy of anemias and sickle cell disease.